MRI MUSCLE DYNAMOMETER

It is useful to be able to make in vivo metabolic measurements (e.g., of muscle phosphocreatinine) with magnetic resonance spectroscopy while subjects are exercising specific muscle groups on a dynamometer. It is the purpose of the present work to design and construct a programmable wrist- and ankle-joint dynamometer for use in the magnetic environment of the NIH 4-Tesla MRI instrument.